New York Regional Center for Diabetes Translation Research

The Enrichment Program of the New York Regional Center for Diabetes Translation Research (NY-CDTR) will serve as command central for coordination of enrichment activities that will include ‘Works in Progress’ seminars and research mentoring, special lectures, seminar programs, workshops, and live and virtual education in type 2 to 4 (T2 to T4) translation research methods. We take very seriously our leadership role in translation research in diabetes and see enrichment as a major venue to bring talented diabetes and related research investigators together within the institutions, across institutions in the surrounding region, and across the nation through our National Resource Core. In alignment with the health goals of the NY-CDTR, the Enrichment Program provides enrichment activities that highlight the work and expertise of the varied and talented diabetes and obesity-related research investigators in our member network. The specific aims of the program are: 1) to strengthen a novel mentoring program in which all Pilot & Feasibility awardees receive faculty support and guidance during conduct of their studies, and participate in “Works in Progress” seminars; 2) to facilitate access to various education and training enrichment activities (live and online) covering T2-T4 translational research topics in diabetes prevention and control and related metabolic disorders; 3) to facilitate networking among NY-CDTR members through media relations, publications, multimedia, social media, internal communication, web and interactive media, and creative services to meet membership collaboration and disseminate research findings and enhance collaboration throughout NY-CDTR membership; and 4) to increase support resources for early stage investigators and enhance participation and outreach within the Enrichment Program. The aims of the Enrichment Program are accomplished by the following: (a) Sponsor or co-sponsor guest speakers on relevant topics to diabetes and obesity translation research; (b) Leverage enrichment activities (e.g., courses, workshops) from other NIH-funded Centers at Einstein, and regional partners, in order to provide high level educational, training and enrichment offerings to NY-CDTR members in the NY region; (c) amplify the work of our members and connect to a broader audience across the translation research spectrum using the Einstein-Montefiore Department of Communications and Public Affairs; and d) partner with the Office of Grant Support to leverage their resources to enhance our programming.